Leveraging implementation science to accelerate adoption of shorter-course radiation for breast and prostate cancer

PROJECT SUMMARY/ABSTRACT
The overall goal of this NCI K08 career development proposal is to facilitate Dr. Erin Gillespie’s
development into an independent investigator in cancer health services research focusing on strategies to
enhance quality and evidence-based care in radiation oncology. This proposal focuses on shortening the
course of radiation from 7-9 weeks to 3-5 weeks (called “hypofractionation”) which is associated with
equivalent cancer control, improved patient-reported outcomes, and decreased costs in patients with breast
and prostate cancer. Nonetheless, adoption has been slow. Dr. Gillespie’s prior work has revealed that the
individual radiation oncologist is highly influential in whether patients with breast cancer receive
hypofractionation or a longer course of radiation.
The overall hypothesis is that radiation oncologists are the linchpin in radiation treatment decision-
making, and that implementation strategies that harness behavioral economics will be most likely to impact
practice change. My primary objectives are to 1) identify and characterize positive deviant radiation oncologists
(high users of hypofractionation) that will 2) elucidate implementation strategies and associate them with
adoption of hypofractionation across various settings, and 3) pilot test a multi-pronged strategy that promotes
use of hypofractionation in preparation for a large pragmatic multi-center controlled trial. The rationale that
underlies the proposed research and training plan is that, with new knowledge about the levers that drive
physician decision-making (beyond knowledge gaps), healthcare leaders and policymakers can optimally
design and implement systems that evoke change. Dr. Gillespie will harness the resources and expertise at
Memorial Sloan Kettering Cancer Center, where she is a faculty member in the Department of Radiation
Oncology and the Center for Health Policy and Outcomes. She is also engaged in research in the community-
based setting through the MSK Cancer Alliance. Her training plan has a foundation of implementation science
that incorporates large dataset analysis, mixed methods, and behavioral economic theory.
In Aim 1 of the proposed study, the investigators will analyze a Medicare dataset that includes claims
linked to prescribing radiation oncologist and organization, and is supplemented by the AMA Masterfile. They
will systematically conduct the first-ever evaluation of implementation strategies in radiation oncology using
mixed methods. Lastly, in Aim 3 the investigators will develop and pilot test a multi-pronged strategy informed
by Aims 1-2 and including audit and feedback. This proposal, together with the new skills Dr. Gillespie will
acquire, will generate new knowledge about the impact of implementation strategies on de-implementation of
long-course radiation – key parameters necessary to design optimal strategies to encourage physicians to
adopt high value radiation. This will specifically support the development of an implementation strategy that will
be tested in a subsequent prospective randomized trial to assess real world efficacy.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it addresses the appropriate use of shorter radiation treatments (called “hypofractionation”) for breast and prostate cancer, a critical step to improving access to high-value patient-centered cancer care. This research proposal will assess variation across the United States in adoption of hypofractionation, and methodically evaluate and pilot test implementation strategies to improve adoption of hypofractionation in a community-based clinical practice setting. The results of this work will generate fundamental knowledge to inform healthcare leaders and policymakers about effective methods to facilitate adoption of evidence-based cancer care, thereby improving access to shorter radiation treatments that improve quality of life and reduce the burden of cancer treatment for patients.